TOPIC 425 - AUTOMATED MOTION EXTRACTION AND ANALYSIS TO QUANTIFY PATIENT PERFORMANCE STATUS

The Karnofsky score (1948) and the Eastern Cooperative Group ECOG PS (1982) are the standard for patient PS assessment and used as a key determinant for entry into a clinical trial and the initiation or continuation of any interventional therapy. Cansera has demonstrated using image analysis of footage from RGB-D cameras to quantify PS as a predictive biomarker in cancer care. RGB-D cameras captured patients performing a physical task in a clinic and patient movement is analyzed to predict PS. The phase I SBIR proposal will address the following technical challenges: 1) creating a reproducible method for data acquisition and extraction from RGB-D cameras; 2) developing a strategy for anonymizing RGB-D image dataset for an open access library; and 3) establishing requirements and designing for different user groups. The successful completion of the project will enable commercial application for a reproducible anonymized method for data acquisition and image capture using a RGB-D camera to objectively
measure human performance providing a quantitative solution.